Determining face representations within and transformations between temporal and prefrontal cortex

PROJECT SUMMARY/ABSTRACT
Circuits of the visual system transform patterns of light impinging on the retina into an understanding of objects
and their behavioral significance, achieving robustness and versatility currently not matched by even the most
advanced computational vision models. Much of this high-level information extraction is thought to occur in the
ventral stream, a pathway of interconnected brain regions which include areas for the processing of faces. The
prefrontal cortex, typically associated with cognitive functions, receives highly-processed visual output from the
ventral stream and also feeds signals back into it, resulting in a recurrently connected visual-cognitive loop. To
address these fundamental questions, this proposal uses face stimuli and the face-selective patches that process
them, including one in the anterior temporal cortex (aTC) in the ventral stream and the other in ventrolateral
prefrontal cortex (vlPFC). The central hypothesis to be tested is that aTC and vlPFC contain qualitatively different
face representations, one emphasizing physical properties, the other meaningful categories, and that this
difference shapes feed-forward and feed-back processing between them. The work proposed here leverages
the advantages of a small, lissencephalic brain, the use of multi-regional high-density electrophysiology, and
mesoscale calcium imaging to determine the spatial organization of face codes with single-cell resolution. Aim 1
will determine how face features are represented in aTC and vlPFC through simultaneous, translaminar
recordings using Neuropixels probes. It will test the specific hypothesis that aTC represents faces in a feature-
specific and physically accurate manner, while vlPFC represents faces holistically and as exemplars of
meaningful social categories. Aim 2 will determine the spatial organization of face representations in vlPFC
through mesoscale multiphoton calcium recordings of thousands of cells simultaneously. It will test the specific
hypothesis that multiple abstract face-related categories are represented within vlPFC in a spatially segregated
manner. Aim 3 will determine the role of vlPFC feedback signals on aTC face representation using dual probe
recordings to test the hypothesis that robustness to ambiguous inputs results from recurrent interaction between
temporal and frontal circuits and reflects category selectivity. This project will make use of modern advances in
neural recording technology to address questions about the precise orchestration of brain activity across regions,
whose disruption is associated with debilitating dysfunctions such as schizophrenia. It will develop a model
system and approaches for mechanistic dissections of high-level perceptual and cognitive functions and
contribute to our understanding of the specific neural circuitry underlying face perception and social cognition
that is known to be perturbed in neuropsychiatric disorders such as prosopagnosia, frontotemporal dementia,
and autism spectrum disorders.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the brain processes information through the precise coordination of neural activity across regions, and the failure of this coordination is thought to underlie a variety of disorders including schizophrenia, autism spectrum disorders, and frontotemporal dementia. Studies proposed in this application will examine the processing of facial information across two cortical lobes with state- of-the-art electrophysiology and optical imaging techniques, providing mechanistic insights into visual and social functions that are commonly perturbed in neuropsychiatric illness. Thus, the proposed research is relevant to the part of the NIH’s mission that pertains to reducing illness and disability.